The Role of Mitochondria in Inclusion Body Myositis

PROJECT SUMMARY/ABSTRACT
Despite being the most common myopathy after the age of 50, inclusion body myositis (IBM) pathogenesis
remains poorly understood. Traditionally, IBM is considered an inflammatory myopathy. However, unlike other
inflammatory myopathies, IBM almost never happens before the age of 40, has histopathological features of
rimmed vacuoles and protein aggregates reminiscent of other neurodegenerative diseases, and remains
refractory to all forms of immunotherapy. Patients continue to progress relentlessly and most become
wheelchair dependent within 20 years from onset. Therefore, there is a critical need to determine the
underlying disease mechanisms that would offer a unifying holistic explanation of the involved downstream
immune and degenerative processes, and help identify new therapeutic targets. Our central hypothesis is that
declining mitochondrial function plays a primary role in IBM pathogenesis, which after reaching a critical
threshold at a certain age, triggers downstream inflammatory and degenerative pathways. The overall
objective of this application is to define the underexplored role of mitochondria in IBM pathogenesis, aiming in
the long term to identify better diagnostic biomarkers and novel evidence-based therapeutic targets for clinical
trials. Therefore, we aim to: 1) Characterize the mitochondria’s morphology, dynamics and interaction with
other organelles in IBM, by using 3D Scanning Electron Microscopy. 2) Identify the specific molecular level of
mitochondrial dysfunction in IBM by a series of cutting-edge techniques. 3) Define the disease-specific
metabolomic and transcriptomic profiles of IBM. Our proposed approach will define the nature and the extent of
mitochondrial dysfunction in IBM, and provide valuable insights into IBM pathogenesis focused on, but not
limited to the mitochondrial pathways.
The candidate is a neurologist with advanced training in Neuromuscular Medicine, Muscle Pathology and
Electrodiagnostic Medicine. The goal for this application is to help him develop laboratory-based skills
necessary for translational research, expertise in Electron Microscopy, and training in Systems Biology
approaches. He will be guided by a multidisciplinary team of well-established researchers who have made
significant contributions to the fields of mitochondrial biology, Neuromuscular medicine and Aging. These
include: Jania Trushina PhD (primary mentor), Anthony J. Windebank MD, and Ian R. Lanza PhD. The career
development plan combines the strengths of the candidate, the mentors and the research institution and will
help enable the candidate to become a successful independent investigator.

Public health relevance
PROJECT NARRATIVE Despite being the most common muscle disease after the age of 50, inclusion body myositis (IBM) remains of unclear etiology and refractory to any form of treatment, with almost all patients eventually becoming wheelchair dependent. Herein, we propose that the mitochondria play a primary role in IBM, and we plan on evaluating the mitochondrial function by a series of very innovative techniques. Our proposal has the potential to clarify underlying disease mechanisms, and identify new diagnostic tools and therapeutic targets.